USE OF SERUM CONTRAST MEDIA LEVELS TO PREDICT CONTRAST NEPHROPATHY

Patients to be enrolled in this research study must undergo a cardiac catherization or dye study in order to better define the presence or absence of heart disease, as well as the severity of any heart disease that is present. One of the potential risks of undergoing a dye study is the possibility that the kidneys may develop some temporary, or more rarely, permanent loss of kidney function from this procedure. This risk of the occurence of a decrease in kidney function is very low in patients with normal pre-existing kidney function, but is increased in those patients that already have some pre-existing loss of kidney function (or renal insufficiency). This research study is designed to determine if we can predict, within eight hours of receiving a dye study, if a patient will develop some loss of renal function. We will obtain five tubes of blood in the eight hours after the patient has undergone the dye procedure which will be used to determine the serum concentration of the dye.